TEAMSS – Transforming Expanded Access to Maximize Support & Study

Project Summary
The Expanded Access (EA) program of the Food and Drug Administration (FDA) provides an opportunity for
patients who either lack therapeutic options or who are ineligible for clinical trials to potentially benefit from the
clinical use of experimental drugs, biologics, and medical devices. This process represents one of the most
immediate forms of translation because an experimental therapy is administered directly to an individual
patient in need. However, the individual nature of EA interventions, the silos of care environments utilizing
them, and the lack of standardized reporting have led to the inability to make broader inferences about safety
or therapeutic potential. A more coordinated approach to EA that can achieve greater integration and yield
more robust information could be transformative for the care of patients with rare or refractory disease. The
NIH Clinical and Translational Science Awards (CTSA) consortium is an ideal network to develop innovative
methods for regulatory navigation and support, oversight, and delivery of investigational products through EA.
We therefore propose a CTSA-based program focused on Transforming Expanded Access to Maximize
Support and Study (TEAMSS).
Our long-term goal is to advance clinical care and translational research by improving patient access to
experimental therapies through a federated, national consortium for EA interventions. The goal of this
application is to develop a CTSA-based network that can demonstrate successful multisite integration of EA
programs, leading to dissemination of best practices. We will pursue this goal by accomplishing the following
specific aims: Develop, demonstrate, and disseminate best practices of network-based Expanded Access
programs across the CTSA consortium; Develop a network for cohort-based Expanded Access programs;
Create a database to standardize Expanded Access data reporting and develop a body of real-world data.
The expected outcome of these aims is to demonstrate that a network-based approach to EA interventions and
outcomes is both feasible and beneficial. We also expect to have achieved a thorough landscape assessment
of EA infrastructure at each TEAMSS hub, as well as the successful dissemination of best practices that are
applicable across the CTSA consortium. This will create a positive impact by, for the first time, creating a
foundation for an integrated, nationwide approach to EA that can improve care for the most vulnerable
patients.

Public health relevance
Project Narrative TEAMSS (Transforming Expanded Access to Maximize Support and Study) seeks to advance clinical care and translational research by improving patient access to experimental therapies through a federated, national consortium for Expanded Access interventions. Expanded Access provides an opportunity for patients who either lack therapeutic options or who are ineligible for clinical trials to potentially benefit from the clinical use of experimental drugs, biologics, and medical devices. By developing this national consortium, we will build a positive impact by, for the first time, creating a foundation for an integrated, nationwide approach to Expanded Access that can improve care for the most vulnerable patients.